Developing Chemical Probes for Inflammatory Pain

SUMMARY
Chronic inflammation affects millions of Americans each year and can manifest in a variety of chronic pain conditions
where normally innocuous stimuli produce pain symptoms. Long-term use of current pain therapeutics, including NSAIDS,
corticosteroids, and opioids, can cause unwanted side effects, and addiction potential can limit their utilization. Recent
studies have demonstrated a clear link between chronic low-grade inflammation and the increase in Chronic Inflammatory
Pain (CIP) conditions. Alternative therapeutic targets are needed for the treatment of these painful conditions. Nuclear
receptors, ligand-activated transcription factors that regulate a variety of physiological processes including metabolism,
inflammation, reproduction, and development, represent key drug discovery targets (second to GPCRs). The REV-ERB
proteins are nuclear receptors which function as transcriptional repressors and direct regulators of NLRP3 inflammasome
components and proinflammatory cytokines (IL-1, IL-18), and regulate the activity of macrophages at sites of cellular
damage. To date, the role of REV-ERB in relation to the manifestation of chronic pain symptoms has not been elucidated.
Due to its role in NLRP3 inflammasome and proinflammatory cytokine regulation, we hypothesize that REV-ERB is a
viable drug target for the treatment of inflammatory pain. Our strategy will leverage the known physiological functions of
REV-ERB in chronic inflammation and use a chemical biology approach to identify novel REV-ERB ligands, with superior
pharmacological profiles, to advance this potential therapy toward clinical trials. Our new preliminary data shows that total
loss of REV-ERB in mice increases mechanical hypersensitivity. Our previous studies demonstrated that pharmacological
activation of REV-ERB had no negative effects in preclinical mouse reward models, suggesting that targeting of REV-ERB
may benefit many chronic pain conditions.

Public health relevance
NARRATIVE Chronic pain, including inflammatory pain and neuropathies, are often associated with long-term activation of the NLRP3 inflammasome at the site of nerve damage. Long-term use of current pain therapeutics, including NSAIDS, corticosteroids, and opioids, can cause unwanted side effects, and addiction potential can limit their utilization for chronic pain patients. We aim to develop novel non-opioid ligands targeting the REV-ERB nuclear receptors, which controls chronic inflammation, to alleviate chronic inflammatory pain conditions.